Parent/Health Care Provider Behaviors & Child's Anxiety

DESCRIPTION (provided by applicant): About 4 million children undergo surgery in the US each year and up to 65% of these children experience significant anxiety and distress before surgery. Not only is high preoperative anxiety emotionally traumatic, but it also leads to postoperative adverse outcomes such as increased pain and analgesic requirements, delayed hospital discharge, and maladaptive behavioral changes. In a study completed at Yale, our group identified specific behaviors by health care providers and parents that can easily be incorporated into a busy practice environment and positively impact children's distress and coping behaviors prior to surgery. Based on these data we developed a Provider Tailored Intervention for Perioperative Stress (P-TIPS) that is aimed at reducing anxiety and distress in children prior to surgery by modifying adults' behavior. A pilot trial conducted at University of California Los Angeles and University of California Irvine successfully demonstrated the feasibility and initial efficacy of P-TIPS and examined dose-effectiveness. The proposed clustered randomized trial of four California children's hospitals, each with a total of approximately 20 anesthesia and nursing health care providers (HCP) will examine the effectiveness of P-TIPS in preventing high anxiety and improving the recovery process in children undergoing surgery. Objective measures of children's preoperative anxiety and postoperative recovery will be collected. The primary aim of the study is to determine if P-TIPS is more effective than standard care for preventing high preoperative anxiety among children undergoing anesthesia and surgery. Secondary aims of the study are to: 1. Examine the impact of P-TIPS on surgical recovery parameters such as postoperative pain, recovery room stay, nausea and vomiting, emergence delirium and maladaptive behavioral changes; 2. Determine if the use of P-TIPS results in higher satisfaction and lower anxiety scores in parents and 3. Determine if HCP in the P-TIPS group display more desired behaviors and less undesired behaviors as compared to the control group. We expect this project to be transformative in nature as in the past all treatment modalities for preoperative anxiety have focused on an individual child- parent dyad. In contrast, this intervention is aimed at health care providers who are likely to treat thousands of child-parent dyads in their career. Once tested for effectiveness P-TIPS will be implemented in hospitals across the country.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study will examine the efficacy of modifying health care providers and parents' behavior in surgical settings. If we find that this intervention is effective in decreasing preoperative anxiety and improving the postoperative recovery in children undergoing surgery, then it can be incorporated into a treatment plan as the standard of care in the US. Preliminary discussions with the American Society of Anesthesiologists, the American Board of Anesthesiology and the Society of Pediatric Anesthesia have indicated the willingness of these organizations to include P-TIPS in residency, fellowship and CME programs. Project Narrative: The proposed study will examine the efficacy of modifying health care providers and parents' behavior in surgical settings. If we find that this intervention is effective in decreasing preoperative anxiety and improving the postoperative recovery in children undergoing surgery, then it can be incorporated into a treatment plan as the standard of care in the US. Preliminary discussions with the American Society of Anesthesiologists, the American Board of Anesthesiology and the Society of Pediatric Anesthesia have indicated the willingness of these organizations to include P-TIPS in residency, fellowship and CME programs. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS About 4 million children undergo surgery in the US each year and up to 65% of these children experience significant anxiety and distress before surgery. Not only is high anxiety traumatic, but research by our group and others indicates that high anxiety in children before surgery leads to postoperative adverse outcomes such as increased pain and analgesics requirements, delayed hospital discharge, and maladaptive behavioral changes (R01-HD037007-01). Our group has also demonstrated in a RCT that preventing high anxiety in children before surgery using a combination of a family centered preparation program and sedatives results in significant improvement in the postoperative outcomes mentioned above (R01-HD037007-06). Unfortunately, while preoperative sedatives and family centered preparation programs are effective, large-scale surveys indicate that these interventions are not widely used in the US because of cost containment issues. We concluded that a fundamentally different approach is needed to address the issue of preoperative anxiety and the resulting postoperative outcomes in children. Our search for such an approach introduced us to the proximal-distal theory that suggested that in acute Increased preoperative anxiety = procedural settings specific adult behaviors directly 1 Worse postoperative recovery affect children's distress and coping behaviors. To (Cohort Study R01-HD037007) examine the validity of this approach in the surgical Decreased preoperative anxiety = setting, we studied about 300 dyads of child-parent 2 Better postoperative recovery and health care providers (HCP) (R01-HD048935). (Randomized Control Trial R01-HD037007) Using sequential analysis, we identified specific Identified specific HCP behaviors that impact HCP behaviors that were associated with children's 3 children's preoperative anxiety distress and coping behaviors. Based on these (Cohort Study R01-HD048935) data, over the past year we developed a Provider HCP intervention was developed and Tailored Intervention for Perioperative Stress (P- 4 proven to be effective in modifying HCP behavior TIPS) that is aimed at reducing preoperative anxiety (Pilot Study) in children via modifying adults' behavior. A pilot trial conducted at UCLA and UCI to demonstrate Test the efficacy of the HCP intervention in reducing 5 anxiety and improving postoperative outcomes feasibility and examine dose-effectiveness and (Current R01 Proposal) initial efficacy of P-TIPS was successful. The proposed clustered randomized trial of four California children's hospitals, each with a total of approximately 20 anesthesia and nursing health care providers (HCP) will examine the effectiveness of P-TIPS in preventing high anxiety and improving the recovery process in children undergoing surgery. Each hospital and all HCP in it will be randomized to either a P-TIPS Group, who will receive the newly developed intervention, or a Control Group who will receive a 2-hour seminar on the management of preoperative anxiety and postoperative pain and otherwise will provide standard care. Objective measures of children's preoperative anxiety and postoperative recovery, as well as adherence measures of HCP will be collected prior and during the experimental period. The aims of this study are to: PRIMARY AIM 1. Determine if P-TIPS is more effective than standard care for preventing high preoperative anxiety among children undergoing anesthesia and surgery. The primary outcome will be observational anxiety in the operating room settings as measured by m-YPAS (Yale Preoperative Anxiety Scale). SECONDARY AIMS 1. Examine the impact of P-TIPS on surgical recovery parameters such as postoperative pain, recovery room stay, nausea and vomiting, emergence delirium and maladaptive behavioral changes 2. Determine if the use of P-TIPS results in higher satisfaction and lower anxiety scores in the parents. 3. Determine if HCP in P-TIPS group display more desired behaviors and less undesired behaviors as compared to control group and whether these behaviors mediate the child and parent-level outcomes. We expect this project to be transformative in nature as in the past all treatment modalities for preoperative anxiety have focused on an individual child-parent dyad and this intervention is aimed at HCP who are likely to treat thousands of child-parent dyads in their career. This intervention was designed within the context of a busy clinical environment and as such is feasible in 'real world' settings. This project is aimed to demonstrate the efficacy of P-TIPS. Once efficacy is established, we plan to move to demonstrate the effectiveness of P- TIPS, which is crucial to avoid the knowledge translation gap. Problem An Intervention A New Clinically Feasible Intervention